Training in Bioinformatics and Integrative Genomics

Project Summary
We propose to continue the Bioinformatics and Integrative Genomics (BIG) pre-doctoral training
program at Harvard Medical School. Since its inception in 2000, this program has provided
rigorous multidisciplinary education in genome sciences for those students with proven
excellence in quantitative fields. The gap between the ability to generate large amounts
genomic data and the ability to efficiently analyze and interpret them continues to grow. Our
program aims to train multi-disciplinary investigators who are capable of both integrating the
genome-scale technologies into their experimental investigations and synthesizing the resulting
datasets into coherent knowledge frameworks and mathematical models.
The BIG training program draws on three significant strengths of the local academic
environment: the breadth of talented investigators at Harvard Medical School and its affiliated
hospitals and research institutes; the rich variety of quantitatively-oriented courses in
bioinformatics and genomics offered at Harvard and MIT; and national leadership of BIG faculty
in genome-scale disease research, including harnessing of genomic approaches to clinical
applications. The BIG pre-doctoral curriculum includes the following: 1) courses in fundamentals
of genetics and molecular biology, taken alongside graduate students in the biological sciences;
2) statistics and machine learning, with focus on their applications to population studies, clinical
medicine and basic biology; 3) survey of the larger scope of biomedical sciences, including
medical informatics and translational medicine. This training program will continue to produce
leaders, both in academia and industry, who are using genomic sciences to advance biomedical
research and its application to medicine.

Public health relevance
Project Narrative Integrating genomics into the practice of biomedical research and medicine is a primary goal of the National Human Genome Research Institute's strategic plan. The Bioinformatics and Integrative Genomics (BIG) Program at Harvard Medical School meets this goal by providing students trained in the quantitative sciences the intellectual tools to integrate genomics with biomedical sciences, access to “big data” from genome sciences and healthcare systems, and faculty mentors who are experts in genomics and bioinformatics. This program will continue to produce leaders who are using genomic sciences to advance biomedical research and clinical practice.